Caries resistance mechanisms in high-risk Indigenous children

PROJECT SUMMARY
There is a fundamental gap in our knowledge whether natural mechanisms protect high-risk children from
caries and arise from microbial interactions of commensal bacteria in the oral cavity, or from the interplay of
microbiome and tooth, mediated by saliva. The long-term goal is to prevent early childhood caries (ECC) in
North American Indigenous children through protective treatments that may also be applicable in the broader
population. The central hypothesis, based on the research team’s strong preliminary data, is that children with
and without ECC differ in one or more key drivers: i) microbially reduced acidogenicity of S. mutans, or ii)
enamel and dentin properties, composition, or biochemical fingerprint. The objective in this application is to
integrate observational and basic science, from associations to experiments that test underlying caries
protection mechanisms in children with high levels of S. mutans. The study rationale is based on strong
evidence that i) Rothia sp. actively control S. mutans acidogenesis, and ii) enamel and dentin differ in
composition between the two groups, with lead, cadmium, and sulfur lower in teeth from caries-free children
compared with the unaffected region of caries-affected teeth. The research team plans to pursue the following
three Specific Aims: Aim 1. Test whether and how Rothia and/or other oral species may mitigate the cariogenic
effects of acidogenic bacteria. Aim 2. Test whether and how tooth properties modulate the susceptibility to acid
dissolution of enamel and dentin. Aim 3. Test how tooth substrate or saliva affect acidogenicity and spatial
structure of biofilms, and whether spatial structure of biofilms grown from ex vivo dental plaque differs between
ECC-affected and CF children. The contribution is expected to achieve high impact by going beyond single-risk
factor studies to investigate caries-protective mechanisms involving microbial genetics, biofilm organization
and tooth composition. The proposed research is innovative, because we shift focus to the small percentage of
Indigenous children with high loads of S. mutans and without caries history, use state-of-the art imaging
techniques of in vitro controlled biofilm growth on standardized enamel chips, and integrate multimodal
analyses of enamel and dentin properties, biochemical fingerprint, and mineral composition. This contribution
will be significant because dental caries disproportionally affects North American Indigenous children. After
successful completion of this project, new mechanistic insights into molecular interactions and physiological
functions of commensal oral flora to reduce acid production in cariogenic species can inform new caries
preventive therapeutic strategies.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because early childhood caries affects up to 90% of Indigenous North American children, and extreme socioeconomic disparities in oral health must be addressed. Successful completion of the proposed research could point to new preventive and therapeutic strategies for dental caries in high-risk populations.